Scanable TELeheaLth Cancer CARe: The STELLAR Program to Treat Cancer Risk Behaviors

Project Summary
This application is being submitted in response to the Notice of Special Interest (NOSI) NOT-CA-23-
041. In the parent grant, we are developing a telehealth treatment program for addressing cancer survivors'
risk behaviors (STELLAR). In early conversations as a part of this work, clinicians have indicated interest in
following patients' progress through STELLAR and providing encouragement along the way. Therefore, this
project focuses on the creation of reports to facilitate patient-provider communication about patients' STELLAR
progress, and an evaluation of these reports on patient health outcomes.
Most oncologists do not discuss risk behaviors with cancer survivors. Time constraints and insufficient
training in addressing risk behaviors are two widespread barriers to this important communication. Activating
this communication is a critical step in supporting cancer survivors' health behavior change, especially as they
progress through a tailored intervention. We will employ user-centered design (UCD) methods to develop
reports that focus on clinicians' priorities and can be easily implemented into existing clinical workflows.
The association between patient-provider communication and patient health outcomes has been well
established in the literature. However, little research has looked at explaining how communication impacts
health. STELLAR provides an opportunity to test defined and explicit communication pathways including
proximal and intermediate outcomes. Through this evaluation, we will be able to better determine the
mechanisms through which oncologist communication results in a reduction of cancer risk behaviors and
develop future communication support tools that focus on activating these specific pathways.
By using UCD methods and studying communication pathways in the pilot trial, we will determine the
effectiveness of EMR reports that summarize cancer survivors' progress through STELLAR. Our aims are to:
1. Identify the type of support that oncologists want to see within the medical record to facilitate
communication with cancer survivors about their risk behaviors and STELLAR progress. We will
use a user-centered design process to create easy to use reports and to ensure we are addressing the
needs and preferences of clinicians.
2. Evaluate pathways through which use of the EMR modification influences patient-provider
communication and subsequent health outcomes. During the STELLAR pilot trial we will collect and
analyze data to evaluate if and how EMR report use changes patient-provider communication and
results in improved health outcomes. We will compare: 1) the interactive self-guided intervention, 2) the
interactive intervention with human coaching, and 3) digital information about PASC, without an illness
uncertainty intervention. We will compare patients enrolled in the STELLAR intervention arm (providers
will receive EMR notifications) to those in the control arm (providers will not receive EMR notifications).

Public health relevance
Project Narrative Most cancer survivors engage in at least on cancer risk behavior (including smoking, physical inactivity, and obesity), yet oncologists often do not discuss health behavior change due to a lack of expertise and time. The proposed study will use user-centered design methods to create EMR reports that allow oncologists to track patients' progress through a health behavior change program (STELLAR) and provide personalized encouragement. We will then evaluate how use of the report corresponds with STELLAR adherence and determine the communication pathways through which patient-provider communication during the pilot affects patient outcomes.